Visualizing Biomedical Research Characteristics

LIST OF SPECIFIC GOALS FOR PHASE II • Develop working software, visualizing variety of research-related data. • Produce relevant, meaningful, and valuable visualizations to address some of the pressing needs of NIH portfolio managers with minimal burden on subject matter experts. Provide powerful analytics support for: • Reporting • Workforce Studies • Scientific Trend Analysis • Portfolio Content Analysis • Program Evaluation • Operations/Organizational/ Institutional Research • Make more data available for analysis. o Semantically enable NETE A|V o Access publically available or licensed science datasets in NETE A|V or via Web Services o Provide capability to load users’ datasets • Re-architect platform to replace current output renderer with interactive renderer, based on HTML 5 / CSS 3 / JavaScript / SVG, which provides: • Cutting edge technology platform • Support for mobile devices • Leap-frog over sunset of Flash technology • Future-proof technology with industry support consolidated behind out • Support for interactive visualizations • Expand the visualization use cases to include visualizations, as specified in this proposal. • Pilot the integration with other visualization tools. • Develop a scalable platform. • Provide easy extensibility for future algorithms. • Develop a high-quality, thoroughly tested system. • Provide integration capabilities to existing NIH reporting applications. • Provide ability to store replicable visualization scenarios. • Develop NETE A|V solution as an aggregator/portal to make solutions developed by clients and the community more accessible. Share portfolios, visualization scenarios and generated visualizations with other users; Social Interaction. • Make training materials available. • Build future architecture on Phase I architecture. Keep JavaEE as the server-side platform.